GFAP as an Alexander disease associated biomarker

ABSTRACT
Alexander disease (AxD) is a neurodegenerative disorder caused by the accumulation of an
intermediate filament protein, glial fibrillary acidic protein (GFAP) in astrocytes. Exciting novel
studies in murine models demonstrate the ability to decrease aberrant GFAP using antisense
oligonucleotide (ASO) technology. These advances offer tremendous hope for this devastating
disease, leading families, advocacy groups, clinicians and researchers to seek prompt initiation
of clinical trials. However, translating these findings into effective treatments is limited by the lack
of data qualifying GFAP as a responsive biomarker for a future clinical trial.
Cerebrospinal fluid (CSF) and blood are accessible fluids for GFAP measurement, and our
preliminary data has demonstrated elevations in both CSF and plasma in AxD subjects over
unaffected controls. However, additional studies are needed to first validate the reliability of GFAP
testing, and, second, interpret the clinical relevance of GFAP elevations. In contrast to some of
the other leukodystrophies, the rate of functional decline is slower in AxD, with a life expectancy
that often spans several decades. Therefore, it is plausible that surrogate endpoints (such as CSF
GFAP levels) would be considered for early stage trials of short duration.
In Specific Aim 1, we will measure longitudinal GFAP measurements in the CSF and plasma of
40 Alexander disease patients across multiple sites. We will test sample stability over various
shipping and storing conditions and assay reliability through intra- and inter-assay measurements.
In Specific Aim 2, we will determine whether GFAP concentrations vary by clinical subtypes of
AxD. The disorder presents at various ages, with different clinical phenotypes, and we will
determine whether these features predict GFAP elevations.
In Specific Aim 3, we will further explore whether GFAP levels predict functional outcome
measures in AxD. We will leverage the longitudinal motor, cognitive, and swallowing tools
collected in Project 1 in this aim.
The expected outcome of these aims is a comprehensive understanding of GFAP levels in AxD.
These investigations will provide a critical foundation of knowledge on which to base the design
of future clinical trials in AxD.

Public health relevance
PROJECT NARRATIVE A clinical trial for Alexander disease (AxD) is expected to launch in the near future after the successful rescue of the murine model of AxD using antisense oligonucleotide approaches to reduce the production of glial fibrillary acidic protein (GFAP); however, such a trial is threatened by the lack of knowledge regarding the measurement of cerebrospinal fluid and plasma GFAP in humans. The present proposal will address the internal validity of multicenter GFAP testing methodology, including intra-assay and inter-assay precision and accuracy, and advance our understanding of variability in GFAP levels by clinical subtypes. Finally, the relationships between clinical subtypes, GFAP levels, and clinical outcome assessments (obtained through the Global Leukodystrophy InitiAtive-Clinical Trials Network [GLIA-CTN]) will be explored.